Artificial Intelligence (AI) Summit

Project Summary
The key objectives of the AI Summit are:
 Open collaboration and engagement with FDA and industry to discuss AI challenges and opportunities
 Identify innovative solutions for implementing AI in across healthcare.
AFDO proposes the AI Summit Scientific Meeting plan to follow this format:
 Years 2022-2026 will be an in-person conference with presentations and facilitated discussions
on how AI is, has been, and will be used in the healthcare industry to advance patient care.
During each meeting, a group of 130+ AI leaders from all areas of the healthcare industry will come
together to present work done in one of the three key working teams: AI in Operations Team (AIO),
Good Machine Learning Practices Team (GMLP), and AI at the Point of Care (AI@POC Team).
AI in Operations Team is an organized, cross-industry discussion group of FDA and industry
professionals working to increase the predictive assurance of product quality across all operations
through the power of AI. The problem this team is trying to solve is to alleviate the anxiety and
hesitancy around expanding use of AI in operations. The goal is to work collaboratively towards
increasing the awareness of AI use, and exploring additional applications.
Good Machine Learning Practices Team is bringing the world of AI activity into one place in order to
increase the awareness of the current good work, but also to collaboratively further solutions that
address challenges related to AI implementation across the industry. The problem this team is trying to
solve is to avoid the risks of unanticipated outcomes, unintended degradation in time, confusion for
users, and incompatibility of results with other software that may use the output of evolving algorithms
from machine learning. This group’s deliverables support the ability of organizations to use AI in a
responsible and effective way.
AI at the Point of Care Team is for physicians, healthcare systems members, and innovators seeking to
leverage AI to improve patient care, clinical workflow, system operations, and reduce unnecessary costs.
The problem this group is trying to solve is to safely and effectively develop and implement AI tools and
identify the resources required to do so. This team’s emphasis is on creating deliverables that provide
maximum Relationships, Outcomes, and Improvements (ROI).

Public health relevance
Project Narrative The relevance of the AI Summit Scientific Meetings to public health is the to bring industry and regulatory members together to advance the healthcare industry’s understanding on how to best make use of artificial intelligence, and to establish industry and regulatory work teams that will collaboratively address AI challenges and develop AI solutions that will improve patient care.